Neuronal Regulation of Low-Grade Gliomagenesis

Project Summary
Gliomas comprise the most common form of brain cancer. In adults and children, high-grade gliomas are the
leading cause of brain cancer-related death, whereas the neurotoxicity associated with the treatment of pediatric
low-grade gliomas (LGGs) frequently results in long-term neurocognitive sequelae. For these reasons, there is
a pressing need to better define the mechanisms that underlie glioma development and progression relevant to
improving treatment and reducing lifelong neurotoxicity. This is especially important for children with the
Neurofibromatosis type 1 (NF1) cancer predisposition who develop low-grade optic pathway gliomas (OPGs)
that impair vision. These NF1-OPGs form during early childhood (mean age, 4.5 years), where they are localized
to the optic nerve and/or chiasm containing the axons of retinal ganglion cells (RGCs) - the neuronal subtype
responsible for transmitting light-induced signals from the retina to the brain. Given the intimate relationship
between these tumors and the optic nerve, a collaborative venture between the Monje and Gutmann laboratories
resulted in the identification of a key regulatory role for neurons in NF1-OPG biology using authenticated
preclinical Nf1 optic glioma mouse strains that histologically resemble their human counterparts. In these studies,
we found that decreasing retinal ganglion cell (RGC) neuronal activity prior to tumor formation prevents OPG
initiation, while reduced RGC neuronal activity attenuates established OPG growth. In addition, Nf1 mutant
(similar to patients with NF1), but not wild-type (normal), optic nerves exhibit increased neuroligin-3 expression
and secretion in response to RGC activity, which is controlled by ADAM10 cleavage. Moreover, neuroligin-3
(Nlgn3) is a potent growth factor for Nf1-deficient OPG cells in vitro and genetic loss of neuroligin-3 in Nf1 optic
pathway glioma mice blocks tumor formation in vivo. Lastly, inhibition of neuroligin-3 shedding using ADAM10
inhibitors reduces Nf1-OPG growth. Based on these exciting preliminary data, we hypothesize that Nf1 mutation
in RGC neurons promotes dysregulated neuroligin-3 signaling that drives the initiation and maintenance of Nf1
optic glioma. In this collaborative R01 proposal, we aim to elucidate the intersection between cell-intrinsic
vulnerability (NF1 tumor suppressor loss) and paracrine influences from neurons in the tumor microenvironment
relevant to understanding the pathogenesis of these common brain tumors in children with NF1.

Public health relevance
Narrative Neuronal activity can promote the growth of high-grade gliomas, but it is not known whether neuronal activity influences low-grade glioma growth or glioma initiation in general. The goal of this proposal is to employ the Neurofibromatosis type 1 (NF1) brain cancer predisposition syndrome as an experimental platform to mechanistically determine whether neuronal activity is a critical driver of low-grade glioma initiation and growth.